Individualized estimates of treatment benefit from hormone therapy for men with prostate cancer

Abstract
National treatment guidelines, including those from the National Comprehensive Cancer Network (NCCN), for
men with localized prostate cancer are based on prostate cancer specific mortality (PCSM) risk and life
expectancy which is driven by other cause (non-cancer) mortality (OCM). While OCM is the dominant risk for
many prostate cancer patients, it has received limited attention in the literature. We developed and validated a
clinically relevant model for OCM and life expectancy using prospective data from the Prostate, Lung,
Colorectal, and Ovarian Cancer Screening Trial (PLCO) trial. OCM varied substantially based on patient
demographics and comorbidities and found that social security life expectancy estimations based on age alone
generated substantially biased estimates. Our team also developed and validated a clinical prognostic model
for PCSM published in JAMA Oncology in 2020 (STAR-CAP). While the importance of competing risks in
prostate cancer is widely recognized, there are no models to date which provide PCSM risk estimates
individualized by OCM risk. Many of the common and important treatment decisions for men with localized PC
include whether to treat with hormone therapy (ADT) and for how long. Guidelines recommend ADT for many
men who are treated without it due to morbidity and questions as to actual treatment benefit for individual
patients. Phase III trials have provided overall estimates of the benefit of ADT in terms of reduction in PCSM
over large groups of patients (e.g. intermediate risk). To date however, there are no tools which provide
treatment benefit estimates for individual patients based on PCSM and OCM risk. We propose to address
these shortcomings through two aims. In Aim 1 we will integrate our model for OCM risk with models for
distant metastases (DM) and PCSM to provide estimates of the absolute risk of DM and PCSM that are
personalized using both PCSM and OCM risk factors. We hypothesize that the integrated model estimates
will differ from clinical ad hoc estimates and significantly improve upon current estimates of PCSM that do not
consider OCM risk. In Aim 2 we will develop a web app which provides individualized estimates of ADT
treatment effect in three common clinical scenarios: RT vs RT + short term ADT in intermediate risk,
RT + short term ADT vs RT + long term ADT in high risk and RT vs RT + ADT in the salvage setting. To
do this we will combine the integrated multistate model from Aim 1 with published hazard ratios for outcomes
of PCSM and DM. Our group is uniquely positioned to carry out this work as we have already developed the
component models, have access to the patient level data for additional analyses and have a track record of
successful development of web apps to aid in clinical decision making. If successful, the tools developed in this
application will provide clinicians and patients the key information they need to make informed treatment
decisions.

Public health relevance
Narrative In this proposal we will develop a web app which will provide validated model estimates of developing distant metastases, dying of prostate cancer and dying of other non-cancer causes. It will also provide estimates for individual patients of how much hormone therapy reduces the actual risk of dying of prostate cancer. This tool will enable clinicians and patients to make informed personalized treatment decisions.